Graduate Program in Cancer Biology Training at Emory University

PROJECT SUMMARY
Cancer represents a collection of diseases that remains the second leading cause of death in the United States.
However, several recent advances in cross-disciplinary research have improved patient outcomes and provided
a tremendous opportunity for continued progress. In order to further the innovation and clinical impact of research
discoveries, a Ph.D. workforce with broad conceptual knowledge across the field of cancer biology research is
required. To ensure successful careers, Ph.D. scientists need an acute awareness of rapidly evolving
technological approaches used in cancer biology research, deep knowledge of specific areas, and critical
thinking skills. To address the need for well-trained, diverse, cross-disciplinary Ph.D. scientists entering the
workforce, we propose the Graduate Program in Cancer Biology Training at Emory University. This Program
will provide an exceptional interdisciplinary training program that is above and beyond Ph.D. programs at Emory
with opportunities for basic and translational research focused on cancer biology. It will be highly integrated
within the environment at the Winship Cancer Institute, the NCI-designated Comprehensive Cancer Center. A
suite of evidence-based learning approaches, experienced research mentors focused on cancer in various Ph.D.
Programs and unique ability to interact across clinical and laboratory disciplines will enable the development of
our trainees' success in academic-, industry- and government-based research careers. The objective of this
Program is to provide a diverse population of predoctoral students with effective training that culminates in 1)
Ph.D. scientists with broad conceptual knowledge who are trained to think critically, effectively, and communicate
their findings; 2) A Ph.D. workforce aware of how to conduct responsible, rigorous and reproducible scientific
studies; and 3) A Ph.D. workforce with training in cross-disciplinary communication and exposure to clinical
application of research findings. To achieve this goal, we will use a core curriculum that includes discussion-
based, active learning approaches to fundamental principles of cancer biology and the development of
presentation skills through didactic classroom and seminar experiences. The importance of rigor and
reproducibility in cancer research is emphasized during all phases of the training for both students and mentors,
with a required course emphasizing this training as part of the courses, seminars, and journal clubs. This program
will have an environment focused on inclusive excellence to ensure the recruitment and retention of students
from diverse and underrepresented backgrounds. Finally, Ph.D. trainees will have unique training opportunities,
including the responsibility to organize and execute symposiums, seminars, rigorous training in ethical aspects
of research, and ample opportunity for close interaction with clinical and research trainees undergoing post-
doctoral fellowship training to invigorate communication-related to translational relevance in cancer.

Public health relevance
PROJECT NARRATIVE This proposal is to support a unique program of predoctoral training in Cancer Biology at Emory University. A suite of evidence-based learning approaches, experienced research mentors, and a unique ability to interact across clinical and laboratory disciplines will enable the development of our Ph.D. level workforce in academic, industry, and government-based research careers, as well as other biomedical research-related careers to enhance understanding the biology of cancer and ultimately reach a cancer-free world. This proposal will ensure appropriate training in rigor and reproducibility, methods to assessing student competencies, and a focus on inclusive excellence to train a diverse cadre of Ph.D. scientists capable of cross-disciplinary communication.